CORE--PHARMACOLOGY

DESCRIPTION (provided by applicant): The mission of the Pharmacology Shared Resource is to provide a stable, centralized resource to the members of the San Antonio Cancer Institute for the design, implementation and evaluation of preclinical or clinical pharmacology studies of anticancer or biological agents in a reliable timely and cost-efficient manner. The services provided by the Pharmacology Shared Resource include: Design of Clinical and Laboratory Studies; Assistance is provided to investigators in protocol design and grant submission of preclinical and clinical pharmacology studies taking into account the requirements for numbers of patients or animals, sampling schedules, limitations of sample volume, sample processing and storage, analytical analysis and budgetary considerations; Specimen Analysis. A wide range of analytical support is provided by developing or implementing suitable analytical or biological methodologies under good laboratory science guidelines for the measurement of drugs or surrogate makers in biological fluids and/or tissue; Pharmacokinetic/Pharmacodynamic Analyses. Pharmacokinetic and pharmacodynamic analyses are performed using both commercially available software and customized pharmacokinetic programs, followed by a report and interpretation of the data; Education. Core personnel provide education and training to students, postdoctoral fellows and SACI investigators through presentations or informal meetings on the performance of preclinical/clinical pharmacology studies. The Pharmacology Shared Resource consists of three 600 square foot analytical laboratories and one 600 square foot molecular pharmacotherapy laboratory, located on the third floor of the UTHSCSA Robert F. McDermott Clinical Sciences Building. Specialized technology provided by the core include analysis of oligonucleotides or gene quantification by capillary electrophoresis and measurement of compounds by LC/MS not quantified by standard analytical methods.